Prevention, Preparedness, and Response (P2R) Consortium

Overall Abstract/ Project Summary The Texas-Utah Consortium for Hazardous Waste Worker Education and Training (The Consortium) leverages two large established education and research centers, both funded in part by the National Institute for Occupational Safety and Health, with a diverse and experienced collection of partners to develop and deliver a full spectrum of high quality education, research and training. The Consortium's primary purpose is to positively and meaningfully impact the health of our communities by providing practical hands-on health and safety training to workers (1) in facilities that generate, label, treat, store, load, transport, receive, unload and dispose of hazardous materials; (2) who prepare for and conduct emergency response activities, including clean up and remediation of hazardous material spills; (3) in laboratories that receive samples of potentially hazardous materials, including potentially contaminated environmental samples; and (4) with the responsibility to prevent, deter or respond to large scale intentional or natural disasters. We place special emphasis on training returning veterans and members of underserved minorities, including African-Americans, Hispanics, Native Americans and Pacific Islanders and we take great pride in utilizing modern and innovative adult teaching techniques. Our long-term objectives are to prepare workers and communities to protect themselves, their colleagues and their environment from exposures to potentially harmful hazardous materials using sound scientific methods and to promote the health, resiliency and financial stability in populations that are most vulnerable to disasters. Geographically, our activities will focus on Public Health Regions 6 and 8, with training delivery in other regions as requested.

Public health relevance
Narrative for Overall Project TheTexas-Utah Consortium for Hazardous Waste Worker Education and Training is a large and established partnership of two long-standing education and research centers; each brings extensive university-based resources and the activities, outputs and outcomes of the Consortium align seamlessly with the missions of these educational institutions. Moreover, the Consortium is made up of experienced and highly qualified faculty, instructors and staff who dedicated to their careers to promoting the health and safety of workers and their communities. The Consortium's relevance is echoed by participants in our training events who appreciate our ability to meet their unique training needs and utilize this training to improve both the safety and effectiveness of their daily activities.